Chitinase 3-like-1 regulates neutrophil cell fate in inflammatory lung disease

PROJECT SUMMARY/ABSTRACT
Neutrophils play an important role in the pathogenesis of several common lung diseases including
pneumonia, asthma, and chronic obstructive pulmonary disease. Yet, no neutrophil-specific therapies are
available to treat these conditions. A deeper understanding of the mechanisms that control neutrophilic lung
inflammation may enable development of such therapies.
Our group investigates chitinase 3-Like-1 (Chi3L1), a secreted immune protein with cytokine-like
properties. In preliminary studies using a murine pneumonia model, we have found that Chi3L1 regulates
neutrophil cell fate. Specifically, we have shown that Chi3L1 suppresses apoptosis, promotes formation of
neutrophil extracellular traps (i.e. NETosis, a pro-inflammatory form of cell death), and worsens lung injury. In
this proposal, we seek to build upon these preliminary findings through four sub-aims. First, we will identify the
receptor on neutrophils that mediates the pro-NETotic/anti-apoptotic effect of Chi3L1. Second, we will elucidate
the intracellular signaling pathways responsible for this effect. Third, we will assess the pathogenicity of Chi3L1
in a murine model of neutrophilic asthma. Fourth, we will use sputum from patients with neutrophilic asthma to
establish the relevance of Chi3L1 in human disease. Successful completion of these aims will provide important
insight into the pathogenesis of neutrophilic lung diseases and help to identify new therapeutic strategies for
these conditions. This research will also provide a rigorous training program to prepare the applicant for an
independent career as a physician-scientist studying neutrophil biology in the lung.
Career Development. To support achievement of these research and career goals, we have assembled
a world-class team of mentors with expertise in each proposed area of investigation including pneumonia,
asthma, neutrophil signaling, NETosis, and translational biology. A tailored curriculum of relevant coursework,
intramural meetings, and national conferences has been developed to reinforce the training gained through
mentored research. Environment. Yale School of Medicine represents an ideal setting for this work given its
collaborative atmosphere, cutting-edge technological facilities, and abundance of internationally-renowned
investigators. The Section of Pulmonary, Critical Care and Sleep Medicine (wherein the proposed research will
take place) is deeply committed to the success of early career physician-scientists like the candidate, as
evidenced by its seven current K awardees. The Department of Internal Medicine is similarly committed, as they
have guaranteed 75% protected research time for the duration of this award. Finally, the candidate is well-
prepared to execute the proposed aims, having received fourteen years of training in biomedical science through
Medical-Scientist and Physician-Scientist Training Programs (MSTP and PSTP).

Public health relevance
PROJECT NARRATIVE Neutrophils are immune cells that cause lung damage in several common respiratory diseases including pneumonia and asthma; however, there are currently no therapies that target these cells. We have found that a protein called chitinase 3-Like-1 (Chi3L1) promotes harmful neutrophil responses and worsens lung disease in mouse models of pneumonia. Here, we propose to use cellular, mouse, and human studies to better understand the effects of Chi3L1 on neutrophils, with the ultimate goal of developing new drugs that target Chi3L1 and prevent neutrophil-mediated injury in patients with lung diseases.